Integrated Health Sciences Core

ABSTRACT (Integrated Health Sciences Core)
The mission of the Michigan Center on Lifestage Environmental Exposures and Disease (M-LEEaD) is
to accelerate research that defines the impact of environmental exposures during vulnerable life
stages and promote translation of research findings to improve clinical and public health interventions
for the mitigation of human disease. In support of this mission, M-LEEaD’s Integrated Health Sciences
(IHS) Core facilitates multi-directional interaction among environmental health scientists, clinical researchers
and practitioners, quantitative research scientists, and environmental health practice professionals, leading to
enhanced translation of research findings into public health practice. In this competing renewal, we build on
successes in strengthening connections between research and community and practice needs, in
partnership with the Community Engagement Core (CEC). The IHS Core goals are: to identify and
facilitate access to human and animal biobanks, to promote multi-directional translational research, to
ensure quality of research designs, to provide statistical support, and to link investigators with services
provided by M-LEEaD cores and other UM resources. The IHS Core offers cutting-edge statistical
methods to advance environmental health research and facilitates translation to practice and policy.
The IHS Core provides a critical linkage function promoting translational scholarship and multi-
directional stakeholder partnerships, through close coordination with CEC. Specifically, the IHS Core
aims to 1) provide Center investigators with high-quality study design, laboratory, and repository
protocols, and statistical support for advancing environmental health research; 2) educate and train
Center investigators, staff, students and practitioners in study design, community-engaged research,
laboratory practice, curation of bio-repositories, and statistical methods through seminars and
workshops; 3) promote interdisciplinary collaborations that foster translational research; 4) maintain
and update the searchable, web-based Kiosk to provide information on human and animal studies and
core services of the M-LEEaD Center; and 5) catalyze multi-directional partnerships, in coordination
with CEC, with practitioners and community members to connect research on environmental risk
factors to locations where people live, work, and play through-out the life-course. The IHS Core
provides center members with both basic/routine statistical support and cutting-edge statistical
methods to advance environmental health. The IHS Core facilitates the M-LEEaD translational
research vision by hosting an environmental statistics and an environmental health practice workshop
series. Dissemination of workshops occurs via the M-LEEaD website, and the IHS Core has achieved
specific impact in addressing environmental health concerns in Michigan (e.g., PFAS/PBB) by offering
presentations, webinars and symposia attended by scientists, practitioners, and community members.